In vivo Macroscopic Fluorescence Lifetime Molecular Optical Imaging

In vivo Macroscopic Fluorescence Lifetime Molecular Optical Imaging
ABSTRACT
There is still great need in better characterizing new targeted therapies in vivo, especially prior to clinical
translation. In this regard, preclinical molecular imaging is a central tool in the targeted drug development pipeline.
However, there is still a lack of integrated imaging platforms that can enable longitudinal (multiple time points)
and spatially-resolved monitoring of complex fingerprints including molecular, metabolic and functional
signatures in the same tumor/subject. This new integrated multiplexing imaging platform will play a crucial role
in the development of the next generation of targeted drugs and elucidating (multi-) drug resistance mechanisms.
Recently, we have demonstrated the unique capabilities of optical imaging in quantifying receptor-target
engagement in live subjects by leveraging fluorescence lifetime. This outstanding achievement was realized
thanks to the combination of instrumental, algorithmic and biochemical innovations to enable, for the first time,
whole-body time-resolved optical imaging based on structured light for 2D or 3D Förster resonance energy
transfer (FRET) imaging in live subjects. Herein, we will further impact the field of optical preclinical imaging and
drug delivery assessment by 1) integrating a cutting-edge high-resolution, time-resolved SPAD array imager for
improved photon collection efficiency, spatial resolution, and portability; 2) we will harness the latest
developments in Deep Learning (DL) for ultra-fast, quantitative, but fitting/iterative inverse solver-free image
formation, in both 2D and 3D providing image formation/processing solutions to facilitate multiplexed imaging; 3)
we will implement new functionalities in our imaging platform to enable the concurrent longitudinal imaging of
multiple clinically relevant target-receptor interactions (e.g. HER receptor family members involved in many
cancers) as well as metabolic and functional status across the whole-tumor region in live intact animals.

Public health relevance
NARRATIVE Following an ever increased focus on personalized medicine, there is a continuing need to develop preclinical molecular imaging modalities to guide the development and optimization of targeted therapies. This research program will combine novel time-resolved cameras as well as deep learning techniques to broaden the impact of macroscopic lifetime imaging with the overarching goal to facilitate multiplexed imaging for a comprehensive assessment of cellular delivery efficacy of multiple clinically relevant drugs (e.g. HER receptor family members involved in many cancers) as well as drug response via metabolic and functional status across the whole-tumor region in live intact animals.